Duke Training Grant in Digestive Diseases and Nutrition

Abstract
The Duke University Division of Gastroenterology has been engaged in the training of clinicians and scientists
in gastroenterology and hepatology since 1965. The Aims of our Program are to: 1). Train young investigators
and develop future leaders in digestive disease research and 2). Create a community that brings together
scientists across our campus engaged in digestive disease research in order to facilitate collaborations and to
provide an outstanding training environment that supports diversity, equity and inclusion. The program offers
positions for three postdoctoral fellows for a two-year training experience, and the program currently has an
additional PhD fellow supported by a diversity supplement. The program includes a Basic/Translational
Science Track and a Clinical Research Track. Our program includes a mentored research experience in a
supportive environment that includes structured mentorship, relevant graduate coursework, and career
development guidance. The program provides a research community that stimulates curiosity and offers
multiple resources. The program faculty members are 12 MD and 13 PhD faculty from 9 departments at Duke
with 17 in the Basic and Translational Research Track and 8 in the Clinical Research Track. The faculty are
40% women and 20% underrepresented in medicine. The training program faculty have many ongoing and
productive collaborations. Our specific aims for this application include: 1) Develop and nurture the pipeline of
researchers in digestive diseases from the undergraduate years through medical school, graduate school and
postdoctoral training. 2) Create a scientific community that values and supports diversity, equity and inclusion.
3) Conduct a recruitment process that identifies outstanding applicants and encourages applications from
women and underrepresented in medicine individuals. 4) Identify mentors and organize mentoring teams to
support the research training and career development goals of the postdoctoral fellows. 5) Provide a mentored
research experience that builds a foundation in research plus career development guidance that will prepare
fellows for an independent research career. 6) Guide fellows through an Individual Development Plan to
provide each postdoctoral fellow the training experiences that will be needed to prepare the fellow for a
successful career. 7) Offer graduate coursework and seminars that teach fundamental research principles. 8)
Provide rigorous training in the responsible conduct of research and methods for enhancing reproducibility in
research. 9) Celebrate science through local seminars, visiting scholars and participation in national meetings.

Public health relevance
Project narrative There is a need for scientists who appreciate the clinical challenges of patients with digestive diseases and then seek to understand the mechanisms of disease. This research training program will provide a high-quality mentored training experience in basic, translational or clinical research. The fellows trained in this program will be prepared for meaningful careers in research that will ultimately lead to new diagnostic tests and therapies for patients with digestive diseases.